Data Sciences Core (Core E)

Data Sciences Core
ABSTRACT
The Tennessee Center for AIDS Research (CFAR) is located in the Southeastern United States, the region
with the greatest number of new HIV acquisitions, and of persons living with HIV. The CFAR continues its fourway
partnership between Vanderbilt University Medical Center (a research-intensive institution), Meharry
Medical College (a burgeoning health sciences center), the Tennessee Department of Health (an academically
engaged state health department), and Nashville CARES (a sophisticated HIV community-based organization).
The Data Sciences Core (DSC) has been a critical component of the CFAR and will continue to pursue its
overarching goal of elevating the quality of HIV/AIDS research. Thoughtful study design, data collection,
statistical analysis, and tool development are essential to high-quality HIV/AIDS research. The DSC has
provided epidemiologic, statistical, and informatics support to HIV/AIDS investigators at the four partner
institutions. The DSC consults with and advises Development Core Award applicants prior to submission,
provides guaranteed statistical/informatics support for award recipients, and actively collaborates with CFAR
investigators at all participating institutions. The DSC collaborates closely with other cores and develops novel
resources, tools, and methods to enhance HIV/AIDS research at the participating institutions and beyond. The
DSC team has broad HIV research experience, including leadership roles in international HIV research
consortia, long-standing collaborations with HIV investigators, experience handling and analyzing large -omics
datasets, and proven track records of developing and deploying modern analytic methods informed by and
beneficial to the HIV research community. The DSC will provide mentorship and training by actively
participating in scientific working groups, sponsoring data science seminars, and providing topic-specific
instruction at walk-in clinics. DSC services are expanding to include analysis support for collaborative projects
with the Tennessee Department of Health and with community partners to conduct analyses within their
secured data environments. The well-attended data science walk-in clinics will continue in both virtual and inperson
formats for investigators at all participating institutions. The DSC, in collaboration with the Advanced
Technologies Core, has also added expertise in high-throughput bioinformatics, so that CFAR investigators
may fully take advantage of state-of-the-art single-cell transcriptomics and related technologies at Vanderbilt.
DSC service offerings are continually informed by user feedback and CFAR strategic planning initiatives. The
DSC will support the mission of this CFAR by pursuing three specific aims: 1) To provide biostatistics and
biomedical informatics support to CFAR; 2) To develop databases, tools, and methods to advance HIV
research in CFAR and beyond; and 3) To provide data science training to CFAR investigators.